The Effects of Complex Humanitarian Disaster on HIV Care Engagement and Health Outcomes among HIV-Positive People Who Use Drugs in Ukraine

PROJECT SUMMARY
This longitudinal, mixed methods study investigates the relationship between disaster-related stressors, social
determinants of health, and health outcomes among HIV-positive people who use drugs (PWUD) in Ukraine
and the strategies that health and social service providers have adopted to maintain access to care. In
Ukraine, people who use drugs (PWUD) and live with HIV are a vulnerable population and PWUD are a key
population in Ukraine’s HIV epidemic, with at least 38% of all people with a new HIV diagnosis and at least
50% of all people living with HIV (PLWH) indicating injection drug use as the route of transmission. Russia’s
unprovoked invasion of Ukraine in February 2022 precipitated massive immediate and potentially long-term
disruptions to all aspects of daily life in Ukraine, with unknown consequences for HIV-positive PWUD. Russia’s
war on Ukraine is both a disaster and a form of mass trauma that involves widespread destruction, loss of life,
and psychological distress for those directly and indirectly affected by it. The impact of mass traumas may
have disproportionately negative consequences for already vulnerable populations, including those who are
economically precarious and socially marginalized. Social determinants of health—the social conditions and
economic circumstances that influence health—are key contributors to HIV care and treatment outcomes. The
specific aims of this study are: (1) 1. To measure the effects of disaster-related stressors (personal,
interpersonal, and environmental) and mediating effects of SDOH and adaptation on primary clinical outcomes
of HIV care engagement, ART adherence, and viral suppression and secondary outcomes of drug treatment
engagement and risky substance use in a longitudinal cohort followed up to 3 years; (2) To qualitatively
characterize at baseline and longitudinally the effects of conflict on social determinants of health and
adaptation trajectories of HIV-positive PWUD; and (3) To explore how service providers who work with PWUD
and PLWH modify policies and practices in the context of supply chain disruptions, workforce depletion, and
population displacement to promote continued care engagement. This project will use an innovative
instrumental variables approach to assess how mass trauma and resulting changes to SDOH causally affect
substance use and HIV outcomes and link these findings to structural and resources changes that resulted
from the war. This approach will leverage a natural experiment in which residence in areas of Ukraine most
affected by the war (proximal to the frontlines) approximates a random assignment to mass trauma exposure.
Identifying how people remain connected to HIV and substance use care in contexts of disruption and the
strategies that health care and social service providers use to keep people engaged have potential broad
transferability. The immediate and longer-term consequences of mass trauma for HIV outcomes are unknown.
Identifying how people remain connected to HIV care in contexts of disruption and the strategies that health
care and social service providers use to keep people engaged have potential broad transferability.

Public health relevance
PROJECT NARRATIVE This proposed study addresses a highly relevant public health question: how people living with HIV and affected by disaster access and remain engaged in HIV care. This study will take place in Ukraine, which continues to experience one of the highest HIV rates in Europe and has been devastated by Russia’s 2022 invasion and ongoing war. The information gained through this study has the potential to inform the development of policies and practices to help people living with HIV maintain access to care in contexts of instability.